Lexico-semantic abilities in early language growth and delay

Project Summary:
Children with language disorders are at risk for a host of negative health and academic consequences, and
represent at least 7% of the school-aged population. This project addresses two critical public-health needs
regarding language disorders: (1) Characterizing early language skill trajectories with the goal of (2) Improving
early identification. The administrative supplement, supported by the Tackling Acquisition of Language in Kids
(TALK) initiative seeks to expand the ability of the parent grant to build a wider array of assessments into a
longitudinal study that examines language development trajectories in children with a wide range of language
skills between the ages of 18 to 48 months. Specifically, this supplement will allow us to add new expertise to
our team that can support new analysis of existing vocabulary trajectories in the dataset (Aim 1), and will
support an additional wave of data collection when children in the sample are 3-years of age (Aim 2).
Specifically, Aim 2 measures will focus on adding measures to assess aspects of language, speech, and pre-
literacy skills that extend beyond the parent grant focus on lexico-semantic skills. These new measures from
Aim 1 and 2 will then support future analysis (Aim 3) of how the new measures from Aim 1 and 2 relate to
planned measures in the parent grant that assess language, speech, and literacy skills at age 4. This project
will therefore advance our understanding of early language growth trajectories in children with and without
early delays in communicative skills, and will enhance our ability to detect early language disorders by
supporting a wider range of potential markers longer-term delays that extend beyond the scope of the parent
grant.

Public health relevance
Project Narrative This project brings in a new team of experts who will support new analyses and contribute new measures towards a broader longitudinal project that captures developmental profiles of language growth from 18-48 months in late talking and typically developing toddlers. This project has relevance for clinicians who are interested in early diagnosis of children at risk for later language, speech, and reading impairments, and will contribute to our understanding of the roots and emergence of these disorders.